PEPTIDE ANTAGONISTS OF LHRH AS GONADOTROPIN INHIBITORS

The objectives of this contract are 1) to design and synthesize LHRH antagonists with reduced histamine releasing properties and 2) to define the receptor-bound conformation for antagonists by NMR studies and to use this information to design more active and longer-acting antagonists.